Understanding the central embryonic vasopressin system

PROJECT SUMMARY
Compelling evidence suggests that the central embryonic vasopressin system has a role to play in sex-specific
brain development and subsequent behavior. The vasopressin system is present and functional during
embryonic development, with sex differences in the expression of the ligand. However, very little is known
about the structure or function of this system. Thus, the working hypothesis of this R15 proposal is that the
central embryonic vasopressin system, and specifically vasopressin 1a receptor signaling, directly contributes
to the development of the neural circuitry that supports social behavior in females and males. To test this
hypothesis three specific aims are proposed. The first aim will define the structural details of the developing
vasopressin system in females and males. The second aim will determine how embryonic vasopressin
receptor signaling impacts female and male brain development. The third aim will establish that embryonic
vasopressin receptor signaling has sex-specific effects on social behavior. The proposed research is
scientifically important because understanding how the embryonic vasopressin system affects sex-specific
brain development and social behavior in mice has implications for humans. Specifically, several
neuropsychiatric disorders with neurodevelopmental origins, many of which have a known sex-bias skewed
towards males, are associated with impairments in social behaviors that have been linked to the vasopressin
system. Thus, the data generated from the proposed experiments will provide critical insights into some of the
shared origins of these disorders and will move us closer to more targeted interventions.

Public health relevance
How the central embryonic vasopressin system contributes to sex-specific brain development and social behavior has not previously been studied. This is unfortunate because, in humans, neuropsychiatric disorders that have neurodevelopmental origins often have impairments in their vasopressin system, a sex-bias skewed towards males, and deficits in social behaviors. Since the neural chemicals, neural substrates, and neural circuits that underlie behavior are evolutionarily conserved, the findings of this work are expected to shed light on how the developing vasopressin system may contribute to the origins of neurodevelopmental disorders that are associated with altered social functioning.